Investigation of Digital Media Use, Anxiety, and Biobehavioral Emotion Regulation in Adolescents

PROJECT SUMMARY
Anxiety symptom onset peaks in adolescence, with an estimated one in three teens experiencing
clinically-significant symptoms by age 18 years. Adolescent anxiety confers risk for adulthood anxiety
disorders, as well as poor outcomes in multiple domains including overall health and interpersonal functioning.
Over the past several decades, the social world of teens has been transformed by pervasive use of digital
media (e.g., social media, messaging apps) ingrained in daily life. Both adolescent anxiety and digital media
use have continued to become increasingly prevalent throughout the COVID-19 pandemic, highlighting the
urgent need for rigorous investigations of longitudinal and mechanistic links between digital technology use
and mental health. Guided by three major gaps in the literature, the proposed study will (1) capture how youth
engage in digital media use in ways that facilitate or disrupt social connectedness, (2) examine when youth use
digital media in the context of momentary affect and anxiety in daily life, and (3) address why digital media use
may be beneficial or detrimental for some by examining mechanistic links among biobehavioral cognitive and
affective functioning, digital media use, and anxiety. In particular, adolescence is a critical period of
neurodevelopment in frontal-subcortical circuitry underlying emotion regulation, the implicit and explicit
processes by which we manage emotions, and a major predictor of anxiety disorders. This study will leverage
an innovative, multi-method (i.e., questionnaires, interviews, reaction time, eye-tracking, EEG) biobehavioral
assessment of emotion regulation coupled with ecological momentary assessment (EMA) of within-person
daily patterns of digital media use, emotional experiences, anxiety symptoms, and emotion regulation
measured longitudinally in teens. We will index youths' emotion regulation strengths and vulnerabilities by (1)
contextualizing emotion regulation within adolescents' daily life, (2) targeting both explicit and implicit
regulatory processes, and (3) capturing biobehavioral aspects of ER that reflect rapid attentional processes,
cognitive control, and flexibility. This work is in line with the Research Domain Criteria initiative to investigate
developmental change within ecologically-valid environments by integrating measurement across multiple
domains [(negative valence (potential threat), cognitive systems (attention, control), social processes
(communication, connectedness), arousal (affective states)] and across units of analysis (physiology,
behaviors, paradigms, self-reports). This research aligns with the NIH-wide strategic plan emphasizing the
need to illuminate the role of technology and media use in development and will contribute to NIMH's Objective
2 by furthering the interrogation of biobehavioral indicators related to anxiety symptom trajectories in youth.
Findings from this research have the potential to elucidate the impact of digital media use on vulnerable
individuals and inform recommendations for healthy technology use.

Public health relevance
PROJECT NARRATIVE Anxiety is among the most common forms of psychopathology in youth, with symptom onset peaking in adolescence, and impairment extending across social, academic, and physical health domains. Over the past several decades, the social world of teens has been transformed by pervasive use of digital media (e.g., social media, messaging apps) but many open questions remain regarding links between online behavior and youth anxiety symptom development. Findings from this project will inform healthy technology use and provide evidence for potential treatment targets by identifying profiles of digital media use in daily life that predict anxiety trajectories, and by identifying mechanisms that explain why some youth may be more vulnerable to detrimental outcomes of digital media use.